Project 2- RCT

Abstract
Project 2 of the Sedentary Time and Aging Research (STAR) Program will investigate how 3 month
changes in standing time, brief sit-to-stand transitions and physical activity (PA) breaks, will impact
biomarkers of healthy aging, and physical, emotional and cognitive functioning compared to healthy living
attention controls. This 4-arm randomized controlled trial (RCT) will occur in the `real world' with
postmenopausal women (N=592) who are not physically active, do not stand up frequently and spend at
least 8 hours sitting per day, i.e. most older adults. The daily behavior targets in each condition of Project 2
(increase standing by 2 hours, increase sit-to-stand transitions by 30 per day, & increase PA breaks by 12)
reflect the treatment conditions explored in Project 1. To date, there have been no RCT studies with health
outcomes in older adults. Our multiple pilot studies, however, demonstrate the feasibility and acceptability
of delivering intervention materials (including standing desks, trackers & ActivPAL feedback) to older
adults and evaluating behavior change objectively with thigh-worn inclinometers. The interventions
significantly reduced sitting time (up to 2 hours a day) and significantly increased sit-to-stand transitions
(up to 40 per day). Increases in PA were minimal in the standing conditions, compared to our PA focused
RCT in 307 older adults which increased short PA bouts. One pre-post pilot found that reductions in sitting
time were significantly related to improved gait speed and decreased depressive symptoms. Project 2 will
assess the impact of the 3 interventions to interrupt sitting compared to the attention control condition at 6
and 12 weeks. We will recruit 592 overweight, sedentary, postmenopausal women who will be randomized
to one of the 4 conditions. We will employ tools such as standing desks, wrist-worn device alerts and
condition-specific, tailored ActivPAL feedback. The primary outcomes are glucose regulation and blood
pressure. Secondary outcomes include mitochondrial functioning (measured by muscle mitochondrial
respiratory capacity), and physical, emotional and cognitive functioning. Exploratory outcomes include
psychosocial and environmental mediators and moderators of behavior change. We will also explore the
moderating effect of age on the intervention outcomes. Project 2 compliments the other projects by
assessing 3 month intermediary outcomes. Project 2 will help validate the novel computational algorithms
optimized in Project 1 and applied to Project 3. In addition, the Biostatistics Core will investigate the
response patterns in Projects 1 and 3 and map them to Project 2. Project 2 will strengthen the public
health evidence of how to interrupt sitting time in older adults, provide specific information on interrupting
sitting as an alternative to longer PA bouts, and explore a range of targeted outcomes related to healthy
aging.